Administrative Core (AC) Core A

SUMMARY/ABSTRACT: Administrative Core A
The Administrative Core (AC) will lead and coordinate operations of all Cores and Projects to assure success
in achieving the strategic goals of the Precision Aging Network (PAN). PAN’s goals are to enable the
development of individualized interventions to maintain health, well-being, and function to optimize cognitive
healthspan and to prevent or reduce the burden of Alzheimer’s disease (AD) and AD-related dementias
(ADRD).
The AC will be led by Carol Barnes and Meredith Hay who have a combined several decades worth of
administrative experience in directing large, complex projects. They will be assisted by the PAN Executive
Committee and Steering Committee and advised by the External Advisory Committee in establishing priorities
for center activities and resources, promoting optimal interactions, resolving potential conflicts of interest,
reviewing and updating the research community, and implementing an ongoing evaluation plan with
appropriate metrics and markers of productivity and impact.
Key functions of the AC also include ensuring a robust data and biospecimen sharing plan, meeting
coordination and follow-up, travel arrangements, financial allocations and reports, compliance with federal and
institutional grants management and reporting requirements, collection, collation and confirmation of evaluation
metrics. Overall progress will be assessed through the development of a multi-year Evaluation Plan with
specific milestones to identify areas for improvement and initiate changes. The plan will be specifically
designed to assess the (a) overall performance of PAN, including the effectiveness of the AC, and (b)
productivity, effectiveness, utilization and opportunities of the Cores and Projects, and also (c) actively engage
the external advisors in evaluation of the PAN leadership. Lastly, the AC will strengthen and expand robust,
effective communication, dissemination and outreach activities by fostering mutually productive interactions
among members of health professional, scientific and citizen communities.
With input from the External Advisory Committee and NIA programmatic leadership, the Project Leads, co-
Leads, Associate Investigators, and key personnel, the AC will ensure that PAN provides a broad-based data,
biospecimen and resource sharing plan to facilitate the rapid and far-reaching use of the unique resources
(biospecimens, raw and processed data, algorithms, and analytical methods) created by PAN. They will also
expand interactions with the leadership and key personnel of other NIA-funded Alzheimer’s Disease Centers
located at the four PAN clinical sites as well as across the country. Additionally, the AC will manage
interactions with existing longitudinal cohorts designed to investigate aging, AD, and/or ADRD.